Zebrafish International Resource Center, Curation and Informatics Admin-Core

P40 REVISION ABSTRACT:
Curation and Informatics Component
The Zebrafish International Resource Center (ZIRC) offers zebrafish, research materials, and diagnostic health
services to the biomedical research community. Currently, ZIRC houses and provides 12,823 genetic lines
(representing 46,127 distinct alleles) and receives hundreds of shipments of new lines each year. However,
ZIRC currently faces challenges in acquiring and managing line-specific metadata, resulting in incomplete or
incorrect data submission and delayed processes. Moreover, the captured data are currently not stored and
shared following FAIR data sharing guidelines. There is an urgent need to address this problem by making
new, line-specific information and metadata available to the public and avoid loss of effort when researchers
and ZIRC staff work with new zebrafish lines.
As a solution, ZIRC proposes to develop a web-based line-specific information platform that will help
standardize metadata submission and streamline data validation, troubleshooting, curation, and public sharing.
We propose to create a web-portal for the submission of fish lines and line-specific metadata by users. This will
create the front-end of the line-specific metadata platform that will facilitate, streamline, and standardize data
submission for submitters and curators. We will curate stocks using the newly developed portal and develop a
back-end database for the management of submitted line-specific metadata. This staging database, accessed
by ZIRC and ZFIN, will harmonize the databases by providing ZFIN identifiers and controlled vocabulary for
ZIRC metadata creation. It also streamlines the review and approval of data, storing information under review
before transferring it to permanent tables for public access. Line-specific data, with supporting metadata, will
be available to the research community via the ZIRC and ZFIN websites. The new database will also expand
our current reporting tools to include line acquisition data, enhancing RPPR/sRPPR reporting with known
identifiers and controlled vocabularies. We will support these aims by ensuring thorough training of ZIRC staff
in programming languages, database management and curation, zebrafish husbandry, lab procedures, and
professional development.